How Do Neurons Maintain Mitochondrial Homeostasis in Vivo?

Project Summary
Mitochondria are critical for neuronal function and must be reliably distributed throughout the entire neuron. To
maintain healthy, properly distributed mitochondria, neurons must coordinate mitochondrial dynamics,
including motility, fission and fusion, and degradation, over space and time. The broad goal of this proposal is
to define mechanisms for spatiotemporal control of mitochondrial dynamics in neurons in vivo. To that end, we
will employ an innovative in vivo imaging approach to measure mitochondrial dynamics in well-defined motion
vision neurons in Drosophila. By combining our in vivo measurements with mathematical modeling, we will
gain mechanistic insight into how neurons maintain mitochondrial homeostasis at the systems level. We
propose three specific aims. In Aim 1 we will determine how neurons maintain steady-state mitochondrial
distribution patterns despite high levels of mitochondrial motility within complex neuronal morphologies.
Specifically, we will test the hypothesis that neuronal architectures are optimized for the robust self-
organization of specific mitochondrial localization patterns. We will use experimental measurements of in vivo
mitochondrial motility and neuronal branching patterns to develop a quantitative model linking large-scale
mitochondrial distributions to branch scaling rules. We will test this model by predicting mitochondrial
localization patterns from experimental measurements of neuronal architecture across morphologically and
functionally diverse Drosophila visual system neurons. We will then test our model predictions by comparing to
ground truth measurements of mitochondrial distributions in EM datasets. In Aim 2 we will investigate how
proper spatiotemporal control of mitochondrial fission and fusion contributes to the maintenance of healthy
mitochondria in distal axons and dendrites. We will test the hypothesis that neurons optimize fission and fusion
rates to both maximize complementation across mitochondria and ensure efficient delivery of newly-
synthesized mitochondrial proteins to distal axons and dendrites. Finally, in Aim 3 we will probe the relationship
between neuronal activity and mitophagy rates in neurons in vivo. Altogether, this proposal promises to provide
a critical mechanistic framework for understanding how neurons regulate mitochondrial movement, fission and
fusion, and degradation to maintain healthy, properly distributed mitochondrial populations in vivo, providing
new insight into the molecular and cellular basis for neurodegenerative diseases.

Public health relevance
Project Narrative Maintenance of a properly distributed, healthy population of mitochondria is critical for neuronal function. Fundamental molecular and cellular mechanisms for coordinating mitochondrial dynamics over space and time in vivo are likely to be conserved in neurons across species. Thus, by determining how neurons maintain mitochondrial homeostasis in a tractable model system—the Drosophila visual system—we seek to provide a mechanistic framework for understanding how mitochondrial defects contribute to neurodegenerative diseases including Alzheimer's disease and Parkinson's disease.